Promoting Healthy Relationships among At-Risk Adolescents: A Feasibility Trial in the Emergency Department

Adolescent relationship victimization (ARV), characterized by physical, sexual, cyber or psychological abuse,
reproductive coercion, or sexual exploitation, remains highly prevalent despite implementation of evidence-
based interventions in schools and community settings. Negative outcomes, including suboptimal academic
achievement, pregnancy, sexually transmitted infections, disordered eating, suicidality, and homicide, result in
significant costs to individuals and society. The emergency department (ED) offers unique opportunities to
promote healthy relationships and mitigate negative impact of ARV among an at-risk adolescent population.
However, current ED-based relationship interventions are limited by 1) disclosure-based delivery, 2)
addressing limited forms of abuse, 3) limited efficacy, and 4) missed opportunities to provide point-of-care
harm reduction resources. The Healthcare Education Assessment and Response for Adolescent Relationships
(HEART) intervention may address these concerns through 1) universal delivery of education and counseling,
and 2) comprehensively addressing the full range of ARV. Previous study by Dr. Miller (co-mentor)
demonstrated efficacy of HEART to decrease ARV. However, HEART requires adaptation for the ED setting,
given significant contextual differences between the ED and the originally intended setting, school health
centers. Dr. Randell, a pediatric emergency medicine physician and candidate for this career development
award, is committed to a patient oriented clinical research career targeting interventions to promote healthy
adolescent relationships. Her five-year career development plan includes structured mentoring and formal
didactics to address critical gaps in her training through acquisition of expertise in theories of behavior change,
clinical trials for adolescent behavioral research, implementation science, and adolescent research ethics. The
proposed study complements other training activities by enabling hands-on experience in intervention
adaptation and a randomized control trial. Following identification of enhancements necessary for HEART in
the ED setting, Dr. Randell will conduct a randomized controlled trial to enable evaluation of eight feasibility
constructs. The hypothesis is that HEART in the ED will be feasible as defined by primary outcomes of
acceptability and efficacy to decrease ARV. The rationale is that this study will produce the first ED-based
intervention to utilize universal education to comprehensively address ARV in conjunction with provision of
point-of-care harm reduction resources. Study findings will inform the development of a larger hybrid efficacy-
implementation study, supported by an R01 submission during the K23 award period. This training and
research plan are consistent with the mission of the National Institutes of Health and the National Institute of
Child Health and Human Development, the Healthy People 2020 objectives from the United States Department
of Health and Human Services, and the 2009 Academic Emergency Medicine consensus recommendations for
addressing public health problems in the ED setting.

Public health relevance
Adolescent relationship victimization (ARV), including physical, sexual, cyber or psychological abuse, reproductive coercion, and sexual exploitation, is a public health problem with broad, lifelong negative outcomes that result in significant cost to both individuals and society. The emergency department (ED) offers unique opportunities to promote healthy relationships among large numbers of at-risk youth, but current interventions are limited by disclosure-based delivery, limited efficacy, addressing limited forms of abuse, and missed opportunities to provide point-of-care harm reduction resources. Our proposal to adapt the Healthcare Education Assessment and Response for Teen Relationships (HEART) intervention for the ED setting will result in a novel intervention that is delivered universally, addresses ARV comprehensively, and links adolescents to point-of-care harm reduction resources to improve health outcomes across multiple domains, contributing to disruption of generational cycles of violence and early childbearing